THE BIRTH DEFECTS RESEARCH STUDY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The Birth Defects Research Program serves as mechanism for the collection and dispersment of samples from individuals with genetic syndromes and birth defects under CSMC approved protocols. The purpose is to establish the clinical and genetic resource materials from patients with genetic syndromes and birth defects. The results of these studies help to contribute to both the diagnosis and possible treatment of these disorders. The purpose of the research program is to provide families affected with these conditions access to ongoing research for a particular rare genetic condition.